RECK as a Therapeutic Target for Atherosclerosis

PROJECT SUMMARY
Despite significant progress in diagnostic and therapeutic strategies and the promotion of a healthy lifestyle,
cardiovascular diseases (CVD), including atherosclerotic coronary heart disease (CHD), remain the primary
cause of morbidity and mortality in the United States. Our long-term goal is to identify new targets for therapeutic
invention to limit the development and progression of CHD. Our immediate goal is to determine whether the
induction of RECK (Reversion Inducing Cysteine Rich Protein with Kazal Motifs) is a novel therapeutic to prevent
the development and progression of atherosclerosis. RECK, a regulator of proteinases, is expressed in vascular
smooth muscle cells (SMC) and macrophages (Mφ), two major cell types involved in atherosclerosis. However,
the biological functions of RECK in atherosclerosis remain largely unknown. We and others have reported that
RECK inhibits the activation of matrix metalloproteinases. Our preliminary data suggest that RECK in SMCs
attenuates inflammatory responses and pro-inflammatory SMC phenotype modulation while inhibiting
extracellular protein degradation. In Mφ, RECK promotes clearance of dying cells via efferocytosis and
attenuation of inflammatory responses. Based on these novel preliminary data, we hypothesize that RECK
induction impedes atherosclerosis by inhibiting inflammation and tissue degeneration while promoting
efferocytosis. Aim 1 will determine if RECK overexpression in SMC-like cells attenuates atheroprogression and
promotes a stable atherosclerotic plaque phenotype via inhibiting inflammatory responses and tissue
remodeling/degradation. We have generated tamoxifen-inducible SMC-RECK overexpressor mice on Apoe-/-
background. RECK will be induced as a therapeutic strategy after the animals develop atherosclerosis.
Primary endpoints include atherosclerotic burden and plaque stability. Single cell RNA sequencing (scRNASeq)
analyses and lineage tracing will help identify cell types and intercellular interactions mediated by RECK
induction. The molecular mechanisms regulated by increased RECK will be analyzed in primary SMCs. Aim
2 will study if RECK overexpression in Mφ-like cells attenuates atheroprogression by enhancing efferocytosis
and suppressing proinflammatory signaling. We have generated tamoxifen-inducible Mφ-RECK overexpressor
mice. As a therapeutic strategy, RECK is induced after the animals develop atherosclerosis. Primary endpoints
will be atherosclerotic burden, plaque stability, efferocytosis, inflammation, and scRNASeq/transcriptome
analyses. Aim 3 will investigate if systemic RECK overexpression attenuates atherosclerosis progression,
aiming to prove RECK as an anti-atherosclerosis agent. Completing these genetic and proof-of-concept
interventional approaches will demonstrate that RECK induction is atheroprotective.

Public health relevance
PROJECT NARRATIVE Despite significant progress in diagnostic and therapeutic strategies and promotion of a healthy lifestyle, cardiovascular diseases, including atherosclerotic coronary heart disease, remain the primary cause of morbidity and mortality in the United States. The proposed project seeks to test and prove the therapeutic potential of RECK (Reversion Inducing Cysteine Rich Protein with Kazal Motifs) induction in atherosclerotic cardiovascular disease in a preclinical model and investigate the mechanisms by which RECK exerts its atheroprotective effects. Anticipated results will lead to the development of an innovative anti-atherosclerotic therapy.